Resuscitation Strategies for Achieving Thrombo-inflammatory Homeostasis

Project Summary This proposal is for funds to support the purchase of an advanced liquid chromatography-mass spectrometer system to support NIH funded work that is aimed at improving outcomes in trauma patients. The instrument is the most advanced mass spectrometer available and will provide direct measurement of metabolites, lipids, peptides, and proteins to address a scientific question related to all four aims of our team science award. Unlike antibody based, or other surrogate measures of biomolecules, mass spectrometry provides a direct measurement for specific identification and accurate quantification. The measurements are highly multiplexed allowing for thousands to hundreds of thousands of molecules measured in a typical experiment. Significant institutional support is being provided to cover the remaining balance required for the purchase and the infrastructure required to ensure long term support and utilization of the instrumentation. The system will be housed within the Shared Mass Spectrometry Resource ecosystem that the PIs of this award also direct. This system will have a significant impact on the biomedical research outlined within the parent RM1 team science award. The proposed mass spectrometer will be a powerful analytical tool for investigators, our collaborators and will enable cutting-edge research. This work will support existing aims, allow for analysis of additional clinical and translation samples to improve discoveries towards developing clinical interventions in the next RM1 cycle and beyond.

Public health relevance
This application is for funds, in part, to purchase a mass spectrometer system to characterize biomolecules. This instrumentation will support our team science award to understand the thrombo-inflammatory events that dictate homeostasis in the injured. Results from this work will enable new biomarkers of coagulation defects and inform new therapeutic approaches to stabilize patients in the acute injury setting.